Genome-based diagnostics for mapping, monitoring and management of insecticide resistance in major African malaria vectors

Project Summary
Malaria is a major cause of mortality and morbidity in Sub-Saharan Africa (SSA) and one of the biggest
impediments to the economic development. The major method for controlling these malaria-transmitting
mosquitoes is through the use of chemical insecticides but resistance has emerged and is a major threat to the
recent reductions in both deaths and malaria infections.
A major challenge facing malaria control program managers is knowing to what extent insecticide resistance is
impacting control and when to take action eg by switching to a new intervention. In the first cycle of this
award we exploited the advent of population genomic technologies to develop an improved understanding of
the evolution and distribution of insecticide resistance mechanisms. In this proposal we describe how we will
integrate this resistance marker discovery work with new functional genomic approaches and large vector
control trials to demonstrate how genomic surveillance can be used to guide vector control.
We will leverage our work on two large vector control trials in East Africa. In Uganda we embedded a cluster-
randomised control trial (RCT) of long-lasting insecticidal nets (LLINs) with, and without, the synergist PBO
into a countrywide distribution campaign. In Kenya together with KEMRI we are conducting an RCT of novel
intervention, Attractive Targeted Sugar Baits. We will use whole genome sequencing of the three major
malaria vectors Anopheles gambiae, An. funestus and An. arabiensis from these trial sites to identify genomic
regions that are associated with insecticide resistance. We will then develop two contrasting models of the
genetics of resistance. The first that assumes that we can accurately describe the likelihood of mosquito being
insecticide resistant to by examining a small number of well characterised markers. This model capitalises on
our recent developments in CRISPR/Cas9 transformation of Anopheles. The second model uses a polygenic
score approach that requires a far larger number of markers, significantly-associated with resistance, but with
no need for an understanding of causal mechanisms.
By screening mosquito collections from the clusters within the RCTs and by, re-analysing the epidemiological
data with the inclusion of the two resistance models, we will quantify the impact of resistance on the
intervention efficacy. We will test whether the model based on a small number of genetic variants has
sufficient predictive power for resistance monitoring or whether a larger number of loci provides superior
predictive power. The former would aid widespread adoption of genetic surveillance of programmes. Finally
through two modelling approaches we will 1. deliver predictions of molecularly-defined resistance at the
administrative unit level in East Africa and 2. integrate these resistance data into transmission models of
falciparum malaria to inform decisions on what is the optimal type of vector control to deploy.

Public health relevance
Public Health Relevance/Narrative Over the last five years the annual reductions in malaria illness and deaths in sub-Saharan Africa have stalled. The previous success of malaria control has been largely due to the scale-up in the distribution of long lasting insecticidal nets and it is thought that insecticide resistance is one of the causes of the slow down . The goal of this research project is to embed genomic surveillance approaches into ongoing vector control trials to accurately quantify the epidemiological impact of resistance and to provide the resources to mitigate its impact on malaria control programmes.